Leveraging Omics and Electronic Health Records Data to study Colorectal Adenoma genetics and Drug Repurposing

Colorectal cancer (CRC) arises mostly from pre-existing colorectal adenoma (CRA). Removal of these
precancerous lesions significantly reduces CRC incidence. However, ~30% of CRA patients will develop
metachronous (recurrent) adenomas after their initial polypectomy. Yet, understanding of the genetic basis of
CRA and recurrence, and identification of therapeutic drugs are currently very limited. Addressing the gap in
genetic studies of CRA, we have recently established genome-wide association studies (GWAS) of ~8,000
CRA cases from European Americans (EA) and African Americans (AA) from the Vanderbilt DNA BioBank
(BioVU). Furthermore, we have recently established Vanderbilt Colonoscopy Cohort of CRA cases after
polypectomy (N=76,664), though a large-scale analysis of electronic health records (EHRs) and pathology
reports. In this application, we propose to extend our efforts to establish the first large GWAS of EA and AA
leveraging unique resources primarily from the BioVU, the Mass General Brigham (MGB) Biobank and All of
Us, and conduct transcriptome-wide association studies (TWAS), methylome-wide association studies
(MeWAS) and proteome-wide association studies (PWAS) to identify risk variants, DNA methylations, genes
and proteins for CRA and recurrence. Specific aims are: Aim 1: Conduct GWAS, MeWAS, TWAS and PWAS
among 25,000 CRA cases (~9,000 recurrence) and 140,000 controls in EA and 6,500 CRA cases (~2,000
recurrence) and 47,000 controls in AA participants. Existing data on colon or adenoma tissue DNA
methylation, RNA-seq, and proteomics from EA (n=1,538) and from AA (n=465) from our parent studies, will be
used to build racial-specific prediction models for DNA methylation, alternative splicing, and alternative
polyadenylation, gene and protein expression. These prediction models will be applied to the GWAS data to
identify risk DNA methylations, genes and proteins, both overall and by recurrence of CRA in AA and EA,
respectively. We will integrate findings from EA and AA to identify risk genes across both populations and
those contributing to racial disparity. We will also perform omics-based drug analysis to identify potential
therapeutic drugs for CRA recurrence. Aim 2: Identify repurposing drug candidates to reduce CRA recurrence
after polypectomy: Combing Vanderbilt (N=76,664) and MGB (N=~55,000) Colonoscopy Cohorts, we have
identified ~39,400 CRA patients (~30% of total CRA cases after polypectomy) with a surveillance colonoscopy
at least one year after previous polypectomy (with ~31,700 CRA recurrence and ~2,600 CRC). We will build a
machine learning and statistical framework upon real-world EHRs to create and compare treated and control
patient groups, and systematically screen repurposable drugs to reduce CRA recurrence and/or CRC risk. Aim
3: Perform functional assays to test the efficacy of six promising drugs in both in-vitro and mouse models.
Given the unique resources and methodological strengths, we anticipate that the study will have significant
potential for the optimization of colorectal polyp surveillance and therapeutic intervention of CRA/CRC.

Public health relevance
PROJECT NARRATIVE Colorectal cancer (CRC) is one of the leading causes of cancer death in the United States, arising mostly from pre-existing colorectal adenomas (CRA). This proposed study aims to use exceptional resources (eg, multi- omics and electronic health records) and cutting-edge technologies to discover susceptibility genes for CRA and its recurrence, and to identify repurposable drugs for CRA patients after initial polypectomy to reduce the risk of CRA recurrence. Results from this proposed study are likely to significantly advance our understanding of the genetic basis of colorectal adenoma development and recurrence, and have significant translational potential for optimization of guidelines for colorectal polyp surveillance and therapeutic intervention of CRA/CRC.